31-P-NMR ASSESSMENT OF SKELETAL MUSCLE IN NORMALS AND HEART FAILURE

The purpose of this study is to determine the metabolic response of the vastus lateralis muscle to isotonic and isometric exercise in normal subjects and patients with chronic heart failure.